Artificial Digit Replacements for Women Veterans with Individual Digit Loss

The largest population of upper limb amputees are those with partial hand amputations. This population
outnumbers all other levels of upper limb amputees by a factor of 10. Therefore, a significant clinical impact can
be made if a product serves this population effectively. The care of Veterans with upper limb amputations
requires a highly individualized approach to medicine. Each Veteran brings a unique presentation to the clinic
including levels of amputation, lifestyles, personal experience, and other medical indicators. They tend to be
highly active individuals with the need for a prosthesis to keep up with their daily life.
Prosthetists and occupational therapists work with each Veteran to provide a personalized medical solution using
available components and technologies on the open market. Often, a return to optimized function is limited by
the solutions available on the market, which provide insufficient durability, function, or a combination. To
compound this issue, no commercially available prosthetic finger is appropriately sized for the full range of female
hand sizes. Consequently, certain women Veterans with partial hand amputations are unable to obtain a
prosthesis that meets their needs.
To date, the VA Biomechatronics Development Laboratory (BDL) has developed a ratcheting prosthetic digit,
the Point Digit, that is now commercially available for use in partial hand prostheses. Through our prior Merit
Award [1I01RX002830], we successfully redesigned and prototyped this technology – the Women’s Digit – to
permit it to be sized for a 5th percentile female while maintaining an industry leading strength to weight ratio and
novel ratcheting mechanism.
The mission of the VA Biomechatronics Development Laboratory is to innovate devices and algorithms in the
field of upper limb prosthetic design. For this project, the BDL will complete a prosthetic solution that will meet
the unique needs of women Veterans and be responsive to the VA RR&D Request for Proposals (RFP) to
develop female Veteran specific prosthetic components. We will build upon our previous work to finalize and
translate this device to the field. We will: 1) finalize development through iterative fitting and testing of the
Women’s Digit and 2) conduct a take-home trial of women Veterans fitted with the Women’s Digit to assess
device efficacy. Our goal is to provide an effective solution for women Veterans to ensure their ability to enjoy
work and home life to the fullest.

Public health relevance
The Women’s Digit is a previously developed ratcheting prosthetic finger that is sized to fit a 5th percentile to 95th percentile female hand. With no electronics or batteries, the cost, size, and complexity are reduced all while increasing reliability and durability. The amputation of full or partial fingers can cause physical, psychosocial, and economic damage to an individual. Replacement of a finger requires a mechanical design that can withstand the forces, torques, and environmental conditions of everyday life. The challenging requirements for an effective prosthetic finger have caused an absence of products for women Veterans with smaller hand sizes. This proposal seeks to address this void through the laboratory evaluation and a clinical take-home trial of the Biomechatronics Development Laboratory’s (BDL) Women’s Digit.